California Environmental Health Specialist Network (EHS-Net) Food Safety and Wate

DESCRIPTION (provided by applicant): Project Summary/Abstract The California EHS-Net Food Safety and Water Safety programs will collaborate with both State and local food and water regulatory programs to conduct the following two joint research projects: 1) Food and Water Safety Risk Factors Associated with Mobile Food Vehicles, and 2) An Assessment of California's Local Environmental Health Agencies' Capacities in 2011. Few studies have examined food and water safety risk factors associated with mobile food facilities, such as mobile food preparation vehicle units (MFPUs). The objectives of this study are to collect data on: 1) the quality of potable water on food trucks; 2) water sanitation practices of food operators, 3) personal hygiene practices of vehicle food workers, and 4) preparation and holding practices for potentially hazardous foods during times of operation. The purpose of this study is to expand EHS-Net's and California's knowledge regarding a wide-range of potential risk factors related associated with MFPUs (food trucks). Knowledge gained will help to identify and reduce risk factors associated with illness, and inform future inspectional and disease prevention efforts for the regulatory community. A number of statewide studies have been conducted prior to 2006 that assessed environmental health capacities, needs and barriers. These studies occurred prior to the onset of the current national recession in 2008. This study will examine current capacities of local California environmental health agencies regarding delivery of core services, and familiarity with and/or implementation of the 10 essential services of environmental health during this era of extreme economic challenges. Where possible, changes in capacities will also be evaluated by comparisons with findings from a previous study conducted in California in 2005. California EHS-Net Water will conduct a water-specific study on the relationship of pool closures to requirements for certified pool operator (CPO) training. Previous studies demonstrate the benefit of CPO certification in preventing recreational water illnesses. The objectives of this study are to collect descriptive data on: 1) county policies on who conducts pool inspections, 2) which counties require CPO certification training; and 3) the relationship between training/certification and pool closures and complaints.

Public health relevance
PUBLIC HEALTH RELEVANCE: PROJECT NARRATIVE - PART A & B, FOOD & WATER JOINT STUDIES (2) Title: Food and Water Safety Risk Factors Associated with Mobile Food Vehicles The purpose of this study is to expand EHS-Net's and California's knowledge regarding a wide- range of potential risks to public health related to food and water safety associated with mobile food preparation units (MFPUs), or "food trucks". It is expected that the knowledge gained will help to identify and reduce risk factors associated with illness and inform future disease prevention efforts. The findings will also be used to inform future intervention strategies for the food and water safety regulatory community. Title: Assessment of California's Local Environmental Health Agencies' Capacity in 2011 The purpose of this study is to examine current capacities of local California environmental health agencies regarding the delivering of core environmental health functions, as well as their familiarity with/and or implementation of the 10 essential services of environmental health during this era of extreme economic challenges when environmental health agencies are expected to do more with the same or reduced levels of funding. Where possible, changes in capacities will also be evaluated by comparing EHS-Net findings with those of a previous California statewide study conducted in 2005. PROJECT NARRATIVE - PART B, WATER SPECIFIC STUDY Title: Pool Closure and Their Relationship to Certified Pool Operator Certification Requirements Although good pool operation and maintenance can reduce the incidence of waterborne disease in swimming facilities, even the best maintained pools may be associated with outbreaks. California has over 80,000 public swimming pools and California regulations do not require certified operators to manage pools and many counties do not require any type of education for pool operators. This study will evaluate if pool operator education requirements decrease the number of pool closure and complaints per year. __SpecificAimsTextDelimiter__ SPECIFIC AIMS - PART A & B, FOOD & WATER JOINT STUDIES (2) I - Title: Food and Water Safety Risk Factors Associated with Mobile Food Vehicles Few studies have been conducted to assess food safety risk factors, and/or quality of water associated with mobile food preparation units, or "food trucks". Also, food vehicles are not usually evaluated in the field during actual times of preparation, storage, assembly, and serving of foods - when most food safety risk factors may occur. Routine vehicle inspections for purposes of annual permitting tend to focus on equipment structure and operation, and on vehicle cleanliness, not on active food preparation, or water quality. The proposed study is novel, as the survey focuses on capturing dynamic practices regarding food and water safety during periods of food truck operations. The primary objectives of this study are to collect descriptive data on: 1) water quality of potable water on food trucks, 2) water practices of food truck operators, 3) personal hygiene practices of vehicle food workers, and 4) food preparation and holding practices for potentially hazardous foods. Findings and recommendations from this study have the potential to change the way local environmental health agencies inspect mobile food preparation units. They may, for example, result in shifting inspectional focus for mobile food vehicles away from office-based inspections and into the field, which may prove to be a more effective way to measure food safety risks. It could lead to policy changes in county government, and changes in the California Retail Food Code. II - Title: Assessment of California's Local Environmental Health Agencies' Capacity in 2011 A number of studies have been conducted prior to 2006 that examined environmental health capacities, needs, and barriers in various states. These studies occurred prior to the start of the current national recession in 2008. The purpose of this study is to examine current capacities of local California environmental health agencies regarding the delivering of core environmental health functions, as well as their familiarity with and/or implementation of the 10 essential services of environmental health during this era of extreme economic challenges. Where possible, changes in capacities will also be evaluated by comparing EHS-Net findings with those of a previous California statewide-study conducted in 2005. The primary goals of this study are to collect descriptive data on 1) current capacities and barriers to service delivery by local environmental health agencies in California, and 2) to identify specific program areas/capacities affected by lost or reduced funding streams. A secondary objective is to, where possible, use previous research findings to evaluate any changes in capacity between 2005 and 2011. The significance of this project is the need to measure the impact of the current economic recession on environmental health program capacity in California. The findings will be shared with environmental health agencies to help re-prioritize core activities. Findings and recommendations may bolster legislative efforts to increase/restore general funding streams for programs that provide core essential EH services in CA. SPECIFIC AIMS - PART B, WATER SPECIFIC STUDY I - Title: Pool Closure and Their Relationship to Certified Pool Operator Certification Requirements A number of studies have been conducted that examined chemical water quality in swimming pools associated with certified/educated pool operators versus non-educated pool operators. These studies have not looked at pool closures and complaints associated with certified/educated operators versus non-educated operators. This study will attempt to survey all counties in California and will compare pool closures and complaints before and after pool certification requirements are implemented. The main objective is to prevent or reduce illness, injury and death related to the environmental risk factors associated with swimming pools. The main objectives of this study will be supported through the following: to collect descriptive data on: 1) existing county policy on who conducts pool inspections (REHS, intern), 2) which California counties require pool operator certification or operator education, and 3) the relationship between training/certification and pool closures and complaints. Findings and recommendations from this study have the potential to change local ordinances to require some type of pool operator training/education. Findings and recommendations may also strengthen legislative efforts to require a certified pool operator at every public pool in CA.